Cross Sectional Association of the Oral Microbiota and the Inflammasome with Oral HPV among HIV+ Adults

PROJECT SUMMARY/ABSTRACT
HPV-infection is the most common sexually transmitted disease (STI), and it accounts for 70% of oropharyngeal
cancers. People living with HIV (PLWH) are disproportionately affected by HPV and are also at an increased risk
of cancer development, even with suppressive antiretroviral therapy (ART), suggesting that ART may not fully
recover oral HPV-specific immunity. Therefore, understanding other underlying factors that could facilitate the
transmission and persistence of HPV in PLWH is crucial for the development of cancer prevention and
surveillance strategies, and reduce the burden of HPV-associated malignancies in PLWH. The oral microbiota
and inflammasome protein complex are essential factors for maintaining immune homeostasis factors, which are
altered by HIV infection and have been observed in the pathogenesis of oropharyngeal cancer. Thus they
represent novel targets for biomarker discovery and therapeutics. Our long-term goal is to investigate how these
factors could contribute to immune dysregulation, and may affect the natural history of oral HPV infection in
PLWH, in order to establish a set of early detection markers for HPV-related malignancies and personalized
treatment interventions. We hypothesize that dysbiosis of the oral microbiome and inflammasome dysregulation
can be risk factors for HPV-related complications and can contribute to the dampening the immune system
promoting subsequent inflammation in PLWH. This cross-sectional study plans to recruit 200 virologically
suppressed PLWH (men and women ≥21 and <49 years old) from a community-based organization, Puerto Rico
(PR) CONCRA, that offers preventive and health services specialized in the treatment of the HIV and STI. PLWH
who attends PR CONCRA constitute a unique high-risk group where the prevalence of both HIV and oral HPV
infection is higher, allowing our team of experts in HIV, HPV, epidemiology, microbiology, oral health and
bioinformatics to establish these relationships with high efficiency. The specific aims of this proposal are: (1) to
characterize the oral microbiota in saliva and investigate its relationship with HPV status and HPV genotypes,
and (2) to determine the association between the levels of inflammasome proteins (NLRP3, AIM2, and caspase-
1, IL-1β and cleaved IL-1β) and inflammation markers (IL-1β, IL-6, IL-8, TNF-α, IFN-γ) with oral HPV infection
and HPV genotypes. After collection of saliva samples, participants will undergo oral health evaluations.
Sociodemographic, behavioral, clinical characteristics, and risk factors will be collected through a questionnaire.
Participants will be on stable, suppressive ART for at least 6 months to minimize inflammatory signals due to
HIV active replication. We will characterize the oral microbiota by sequencing the 16S rDNA gene and HPV
genotypes by PCR. Inflammasome proteins and inflammatory markers will be measured by Western Blot and
multiplex ELISA respectively.

Public health relevance
NARRATIVE The oral microbiome and the inflammasome protein complex are novel potential risk factors for HPV transmission, persistence and carcinogenesis in people living with HIV. Puerto Ricans rank 5th in terms of HIV incidence in the USA, have a significant burden and disparity of HPV-related cancers among people living with HIV, and cancer is the first cause of death, thus they are a priority group for cancer prevention. Determining the relationship of the oral microbiota, inflammasome protein complex and inflammation markers with the natural history of HPV infection and carcinogenesis will help define screening guidelines and establish priorities and preventive public health strategies to reduce the risk of subsequent cancer, as well as personalized therapeutic strategies targeting both the microbiome and the inflammasome in the oral cavity in subjects with impaired immune response.